Artificial intelligence enabled Stroma-Weighted Automated Grading system to improve risk stratification in Black Men

PROJECT SUMMARY / ABSTRACT
A significant disparity in prostate cancer (PCa)-associated mortality is observed in Black men, who are twice as
likely to die of prostate cancer than White men. Multiple factors contribute to Black men’s disproportionately
higher cancer burden. Our group and others have demonstrated that tumor biology plays a significant role in the
observed disparities, emphasizing the need for risk stratification tools for the early detection of lethal PCa
phenotypes in Black men. Our long-term goal is to introduce a novel label-free Stroma Weighted Automated
Gleason Grading (SWAG) system for improved risk stratification of PCa in both races and nominate molecular
drives of disparity for therapeutic intervention. The overall objectives of this application are to (i) annotate H&E
and Multiphoton microscopy (MPM), and second harmonic generation (SHG) images with all glandular and
stromal features of PCa, developing an Artificial Intelligence (AI) enabled SWAG system for risk prediction, and
(ii) to define and validate the molecular drives of racial disparity using spatial transcriptomics and multiplexed
CRISPR approach in vivo. The central hypothesis is that SWAG risk prediction will accurately estimate the risk
of specified prostate cancer outcomes. The rationale for this project is that the development of the SWAG system
is likely to offer a strong scientific framework whereby new strategies for the early prognosis of PCa. Two specific
aims will test the hypothesis: In Aim 1, we will develop a compendium of H&E and MPM/SHG images that
captures all major glandular and stromal patterns of prostate cancer from 450 Black and White men’s tumors
with outcome data. Next, we develop a) a machine learning (ML) tool for automated annotation of glandular and
stromal features in both H&E & MPM images and develop the race-specific AI-enabled MPMSWAG system.
Finally, we will test the performance of the SWAG system in risk prediction utilizing large training-validation
primary cohort and secondary validation multi-institute cohorts. In Aim 2, we will perform an in-depth
transcriptomic analysis of MPM-AI-identified driver (stroma-activated) regions using a spatial
transcriptomics/proteomics approach and evaluate how the identified novel gene signatures contribute to
adverse pathology using a multiplexed lentiviral CRISPR approach in GEM model. Our unique disparity PCa
cohort and bulk gene expression data will validate the novel gene signature. The proposed research is innovative
because of its focus on an AI-enabled, stroma-inclusive risk predictor tool that utilizes a label-free microscopy
imaging approach. The proposed study is significant as it provides a strong scientific justification for the continued
development of an MPM-SWAG inclusive, integrated model in a future iteration of these studies. Comprehensive
molecular profiling and validation will provide significant functional and mechanistic insight into cancer
vulnerability in Black men compared to their White counterparts. Ultimately, the combined knowledge obtained
has the potential to develop innovative risk predictor tools for PCa in Black men, fostering faster adoption in
routine clinical decision-making.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on the development of an AI-enabled stroma-weighted automated Gleason grading system (SWAG) for early risk stratification of prostate cancer in Black men. Once such a strategy is developed there is potential for faster adoption in routine clinical decisions and risk stratification. Thus, the proposed research is relevant to the NIH's mission and goals that pertain to enhancing health and reducing illness by early diagnosis of prostate cancer.